Cancer Center Administration

ADMINISTRATION: PROJECT SUMMARY
Administration, led by the Associate Director for Administration and Planning (ADAP), Sharon Levy, supports
achieving the Georgetown Lombardi Comprehensive Cancer Center (LCCC) vision through executing and
tracking strategic planning, fostering innovative collaborative science, driving equity and career development,
and ensuring alignment with catchment area needs. Administration, encompassing 16 direct and 8 secondary
FTEs, provides support to the Consortium comprising Georgetown University (GU), based in Washington,
DC and the John Theurer Cancer Center (JTCC) of Hackensack Meridian Health (HMH), which is
headquartered in NJ. Supporting three Research Programs, nine Shared Resources, and 109 members
focused on basic, translational, clinical, and population-based cancer research, Administration manages an
annual operating budget of $73.3M that includes $21.9M (ADC) in cancer-relevant, peer-reviewed funding,
$16.9M ADC in other grants and contracts, and an annual institutional budget of $34.5M as well as a separate
$129.82M in institutional investments from GU, MedStar Health (MH), and HMH for Consortium-related
activities. Institutional investments are deployed at the Director’s discretion, ensuring that investments are
aligned with LCCC’s strategic plan. Levy assumed leadership of the administrative team in October 2020
when she was promoted from CCSG Administrator to ADAP. Under Levy’s guidance, Administration has
considerably expanded its role in overseeing consortium administrative operations at all sites. This required
development and implementation of robust processes to foster science across the DC and NJ campuses
including revised membership criteria and technology investments to build out infrastructure across the
Consortium (OnCore, Idea Elan, Shiny App grants database). Administration has fostered research program
restructuring, development and expansion of Community Outreach and Engagement, Cancer Research
Training and Education, clinical research infrastructure, and establishment of the new Diversity, Equity and
Inclusion office supporting the Plan to Enhance Diversity. These changes have resulted in a 61% increase in
cancer-relevant, peer-reviewed funding, the recruitment and onboarding of 30 peer-review–funded faculty
members, expansion of shared resource usage across the consortium with a high satisfaction rate, and a
new 2021-2026 Strategic Plan.